Core B - Large Animal Core

ABSTRACT
(Core B)
Large Animal Model and Electrophysiology Core
Experiments in large mammals are a defining feature of this P01. All three projects require analyses of cardiac
function in neonatal or adult pigs, but the housing, surgical, and analytical requirements are too expensive to be
conducted in an individual laboratory and typically require expertise in the use of specialized and sophisticated
equipment. Thus, the Large Animal Core (Core B) will provide a centralized facility for all surgical procedures
(e.g., induction of myocardial injury, treatment administration, perioperative care), cardiac functional
assessments (magnetic resonance imaging [MRI], hemodynamics), and electrophysiological evaluations
(programmed electrical stimulation, implanted loop recorders, optical mapping). Core B will be located at the
University of Alabama at Birmingham in the Cardiac Rhythm Management Laboratory (CRML), and animals will
be housed at the adjacent Animal Resource Program (ARP). Collectively, these two facilities have all of the
resources and equipment needed to conduct our proposed experiments and are staffed by an exceptionally
skilled, efficient, and experienced team of investigators, cardiac surgeons, veterinarians, and technicians. The
responsibilities of Core B are organized under the following three Specific Aims (SAs): SA 1, Induction of
myocardial injury in neonatal and adult pigs; SA 2, Delivery of experimental therapy (i.e., transplantation
of engineered human myocardial tissue patches [hMTPs] or state-of-the-art [AAV- or modRNA-mediated] gene
delivery); and SA 3, Electrophysiological and functional assessments. Core B will also collect tissues,
prepare biological samples for histological and molecular analysis, coordinate the shipment of tissues and
samples to all Projects, and ensure that all experimental data, protocols, reports, and other documentation are
securely stored, archived, and shared among Projects and Cores. Notably, all experimental procedures will be
rigorously and consistently defined and executed for all Projects, which will accelerate the pace of scientific
discovery by enabling us to draw valid conclusions from comparisons across the full range of experiments
conducted under this PPG.

Public health relevance
NARRATIVE (Core B) Large Animal Model and Electrophysiology Core All three Projects in this P01 include experiments in neonatal and adult pigs, which are typically too complex and expensive to be conducted in an individual lab. Thus, by providing a centralized facility for all surgical procedures, functional assessments and electrophysiological evaluations, the Large Animal Core (Core B) will maximize data quality and experimental efficiency while minimizing the costs associated with these studies.